Admin-Core-001

The proposed research project work is a pre-implementation study that will fill gaps in our knowledge around cancer screening and risk reduction services among gender-expansive patients (individuals who identify as transgender and those whose gender is broadened from society’s notion of gender) compared to cisgender patients. With this supplement, the BRIDGE-C2 Center has two main aims: Aim 1: Examine the experience and patterns of care for cervical cancer screening and results, and tobacco use status and cessation services among gender-expansive patients compared to cisgender patients seen in OHSU primary care clinics. Aim 2: Provide mentored research training and career development to Mr. Chen, a post-master’s degree trainee, by implementing didactic coursework, experiential activities, opportunities to attend and present at conferences, mentorship for research and professional skills, and clinical shadowing.